Simple, low cost assay for detection of HIV-1 antiretroviral resistance in resource-limited settings

Antiretroviral therapy has become a reality in resource-limited settings thanks to entities such as PEFAR and the Global Fund. However, contrary to the therapeutic choice flexibility in developed countries, all patients go on reverse transcriptase inhibitor (RTI)- based first-line regimens with more expensive protease and integrase inhibitor-based regimens being reserved as second-line therapy for those who fail initial treatment. RTI efficacy is compromised to a large degree by resistance. Because of cost, however, resistance testing is not performed and a high percentage of individuals fail treatment because of pre-existing resistance. This has undermined the efficacy of treatment rollout and has created an urgent clinical need. The solution is implementation of a simple, inexpensive assay for detection of resistance to first-line RTI-based regimens. We have exploited a novel polymerase, with extraordinary requirement for base pairing at the 3´ end of the primer/target template, to create an allele specific (AS)-PCR assay that uses standard PCR and simply scores for resistance by the presence of amplification products. This format brings the cost of resistance testing down to one- tenth of the cost of current, gold-standard genotyping assays and would make it feasible, for the first time, to initiate wide-spread resistance testing in resource-limited settings. The proposed research will have 3 specific aims: 1) Aim 1: Design and optimize the AS-PCR assay to detect the six mutations that at clinically relevant frequencies confer resistance to first line antiretroviral therapy commonly used in resource-limited settings and assess the performance of the assay after modifying the primers by adding detection markers. 2) Aim 2: Determine the limits of multiplexing to minimize the number of reactions and reduce assay cost. 3) Aim 3: Assess the discriminatory capacity of the assay on validated HIV-1 sample panels with multiple clades and determine level of concordance with patient samples previously characterized by commercial genotyping assays. Completion of these aims will lead to a phase II submission focused on optimization of the assay for utilization in resource limited settings.

Public health relevance
Drug resistance to antiretroviral therapy for HIV infection is a serious clinical problem without cost-effective solutions in resource-limited settings where standard genotypic resistance assays are unaffordable. We have exploited a Taq polymerase that absolutely requires a terminal 3´ base match that, with appropriate primers matched to resistance-associated polymorphisms, forms the basis for a low cost allele-specific PCR resistance assay. The presence of resistance will be scored by the presence of DNA amplification products that can be detected simply and cost-effectively thereby making widespread resistance testing a possibility in resource-limited settings.